Tufts Post-Baccalaureate Research Education Program

The Tufts Post-Baccalaureate Research Education Program (PREP) provides recent college graduates from
groups underrepresented in the biomedical sciences with innovative training that integrates career and cultural
skills with intense research training as a means to transition to and excel in top-ranked biomedical PhD or
MD/PhD programs. Our mentors are high-achieving multidisciplinary faculty drawn from six graduate programs
at Tufts, specifically screened and trained as mentors for the PREP program. Trainees work on independent
research projects akin to graduate students thesis projects. The program complements hands-on research
training with a unique year-long PREP course designed to advance analytic, quantitative, and statistical skills in
basic science, and to develop oral and written presentation skills. Another important element of the Tufts PREP
program is that each trainee affiliates with a PhD program at the Tufts Graduate School of Biomedical Sciences
(GSBS) and participates in its academic and social activities. This affiliation fosters the trainee’s self-identification
as a research scientist and prevents isolation. We also implement the use of Individual Development Plans
(IDPs) and provide training for both the trainee and the faculty mentor to maximize their benefit. Trainees then
receive individualized support during the graduate school application process. We continuously adjust and
improve the program based on trainee and faculty feedback and a robust evaluation strategy that monitors the
effectiveness of all program elements. The Tufts PREP receives generous support from the University and the
School of Medicine, which together provide funding for three new trainees each year. This high level of support
underscores Tufts’ strong institutional commitment to the PREP program and to promoting diversity in the
biomedical sciences. The success of our training program is illustrated by over 50 research publications
generated by our PREP trainees, including nine for which the trainees were first authors. Moreover, 75% of the
trainees who completed training over the last 5 years entered graduate biomedical programs, improving on our
outcomes of the prior 15 years (70%). In this renewal application, we restructure our program to shorten time in
training to one year and add innovative programming to further increase success. New components include an
introductory course designed to help incoming trainees identify strategies to build confidence and resilience, self-
identify as a scientist, engender a sense of community, and establish support networks. A new module in the
PREP course will focus on critical thinking and scientific practice as well as rigor and reproducibility. Trainees
will be required to take a GSBS graduate biomedical course to introduce them to the rigors of graduate school
and build their academic portfolio. They will also participate in a new program that will provide continued coaching
after they enter graduate school. With strong support from the institution, faculty, and broader Tufts community,
Tufts PREP will augment our URG trainees’ academic, scientific, and social skills essential for success in
graduate school, and contribute longterm to a more diverse biomedical workforce and biomedical leadership.

Public health relevance
Narrative The Tufts Post Baccalaureate Research Education Program (PREP) prepares recent college graduates who are members of underrepresented groups with the tools to enter into highly ranked biomedical PhD or MD/PhD programs, succeed and go on to join the next generation of scientific leaders. The program connects each trainee with one of our PhD programs and combines hands-on research training with a faculty mentor and a faculty research advisory committee with classes and workshops that help trainees self-identify as a scientist and develop the skills necessary to succeed in a research career.